IGF::OT::IGF. Enhanced Research Network Informatics Exploration (ERNIE). 9/30/2018 - 9/29/2020. Base Award N44DA-18-1216.

Informatics Exploration (ERNIE). 9/30/2018 - 9/29/2020. Base Award N44DA-18-1216.